RNA-dependent RNA Polymerase

Abstract
The RNA-dependent RNA polymerase (RdRp) drives viral evolution by mediating both genetic drift (mutation)
and genetic/antigenic shift (recombination) of RNA viruses. RdRp speed and fidelity contribute to the rate of
mutation and formation of the mutant swarm, a well-established determinant of viral fitness and pathogenesis.
For more than two decades, we have used the RdRp from poliovirus (PV) as a model system to elucidate
fundamental biochemical and biophysical principles governing speed and fidelity of nucleotide addition. A major
conclusion of this work is that both speed and fidelity are controlled by the dynamics of a conserved array of
amino acid residues in the active site. Importantly, these dynamics can be manipulated genetically or exploited
pharmacologically, thus contributing to the creation of attenuated strains and antiviral agents.
RNA recombination in PV occurs by a template-switching mechanism, a process in which the RdRp initiates
elongation on one template (donor) but completes elongation on a different template (acceptor). PV RdRp is
sufficient to catalyze template switching in vitro. However, the trigger(s) and mechanism of template switching
remain largely unknown. Using a novel cell-based assay for PV RNA recombination, the Evans laboratory
observed a direct correlation between RdRp infidelity and the frequency of RNA recombination. RdRp
misincorporation frequency as a biochemical property governing template switching was not expected but
motivated our foray into the study of RNA recombination. Over the past five years, we have established an
experimental paradigm to elucidate the mechanism of RdRp-catalyzed RNA recombination, discover
biochemical and biophysical properties and structural determinants of the RdRp governing RNA recombination,
and reveal the biological consequences of perturbations to the mechanism and/or efficiency of RNA
recombination.
Here, we will utilize our experimental paradigm to achieve the following: (1) Link structural determinants of
the RdRp to elementary steps and mechanisms of RNA recombination; (2) Investigate the impact of RNA
modifications on elongation and recombination by the RdRp; and (3) Reveal the mechanism and biological
function of forced-copy-choice RNA recombination.

Public health relevance
Project Narrative RNA viruses represent an existing and emerging threat to US public health. The proposed studies will create important knowledge that should contribute to development of strategies to treat and to prevent RNA viral infections, including those of current concern: ebola virus, enterovirus D68, and Severe acute respiratory syndrome coronavirus. Achievement of the goals of the application will provide novel targets and mechanisms for development of vaccines and inhibitors to prevent and to treat infections by RNA viruses.